Pediatric Adverse Event Risk Reduction for High Risk Medications in Children and Adolescents: Improving Pediatric Patient Safety in Dental Practices

A narrow margin of safety exists in the care of pediatric dental patients, and this often occurs in practice settings
with less information on patients’ full medical history that is crucial for the safe practice of dentistry. Although
dentists administer and prescribe a limited number of medications in routine practice, many of these medications
carry a high risk for human error and complications. High-risk medications are frequently prescribed and
administered by dentists to children and have resulted in serious unintended consequences, including adverse
events – such as death – during conscious sedation or general anesthesia, and the overprescribing of opioids.
More than 100,000 pediatric dental sedations are performed annually in the U.S. The most common medications
used for these procedures are benzodiazepines, opioids, and general anesthetics. All are associated with serious
adverse events, including hypoxemia, respiratory depression, airway obstruction and death. Most Americans
have their first exposure to opioids in their youth following third molar extraction. This use of prescription opioids
has been associated with an increased risk of opioid misuse into adulthood. These trends in early adulthood and
case reports of pediatric deaths occurring following dental sedation procedures make clear the urgency to
understand and implement best patient safety practices in the dental care of children. Yet, U.S. data on
medication prescribing patterns of pediatric dentists, evidence-based prescribing and community dental
providers’ attitudes toward implementation of pediatric patient safety is scarce. Although efforts and resources
exist to curtail overprescribing of opioids and best patient safety practices in pediatric sedation, most
interventions are focused on physicians and advanced practice providers (i.e., nurse practitioners and physician
assistants) and may fail in broader implementation to pediatric dental practices. The objective of this mixed-
methods study is to improve high-risk pediatric prescribing patterns among dentists by identifying current
prescribing patterns associated with poor health outcomes that could be targeted for intervention. To
accomplish this objective we aim to: (1) determine the extent to which high-risk medications are prescribed
to pediatric dental patients and rates of poor patient outcomes in a population-based sample of commercially-
and publicly-insured children; (2) [Examine] dentists’ attitudes towards medication safety when prescribing high-
risk medications and decision-making when prescribing high-risk medications for pediatric patients; and (3)
[Develop and pilot a checklist to facilitate treatment decisions that best promotion medication safety in pediatric
dental care]. We anticipate this study will close the knowledge gap on dental prescribing patterns of high-risk
medications to children, association with poor patient outcomes, and determine dentist perceptions of the safety
of these medications. [This mixed-methods study will design and implement an evidence-based intervention to
minimize harms from high-risk medications and improve safe dental practice to children and adolescents.]

Public health relevance
High-risk medications for anesthesia, sedation and pain are frequently prescribed and administered by dentists to children and have resulted in serious unintended consequences, but unique challenges with prescribing high-risk medications to pediatric dental patients are not well understood. Understanding patterns of dental prescribing and factors associated with adverse safety outcomes can inform training models and interventions to improve evidence-based practice, ultimately decreasing risks of serious adverse events and mortality among children. Thus, this project is relevant to the NICHD high research priority to improve systems of care which can mitigate medical errors and advance child health.